3/5 Selective Antipsychotic Response to Clozapine in B-SNIP Biotype-1 (CLOZAPINE)

Project Summary
Treatment advances in psychosis are limited by the use of phenomenology-defined diagnoses based on
symptomatic outcomes, rather than by neurobiological constructs monitored by quantitative characteristics. The
Bipolar-Schizophrenia Network for Intermediate Phenotypes (B-SNIP) uses biomarkers to define psychosis
subgroups with the goal of testing the advantages of B-SNIP biomarkers for diagnostic and therapeutic decisions,
consistent with principles in the NIMH Strategic Plan (NSP). With >3000 phenotyped psychosis probands,
relatives and healthy controls (HC), B-SNIP has a multilevel biomarker library for psychosis and used that library
to re-conceptualize psychosis subgroups as biomarker-defined Biotypes (B1, B2, B3), where B1 and B2 are the
low cognition/high symptom groups and B3 shows lower symptoms and relatively normal cognition. We
replicated Biotypes in a new sample, “forging a future where measures of an individual’s … neural and
physiological state will form the basis of an increasingly specific and informative diagnosis” (NSP). In this grant
we propose that B1, with its low cognition and low cortical activity, will respond uniquely to clozapine, a drug
which will generate active cortical attractor networks in B1 to support symptomatic improvement.
Clozapine is the most effective antipsychotic drug (APD) with unique clinical efficacy. It is the least used APD
because its side effects are serious (neutropenia, myocarditis, seizures) and its administration complex. A
predictive biomarker would allow targeting of cases most likely to respond and improve prognosis in psychosis.
B-SNIP has shown that clozapine is associated with increases in EEG measures of alpha/theta power, and we
identify this increase in time periods without stimulus processing requirements as intrinsic EEG activity (IEA),
across all Biotypes. Because B1 cases express low IEA, clozapine’s action to increase EEG power will be
normalizing for this psychosis subgroup, with increased cortical attractor states. Because B2 express
accentuated IEA, clozapine is associated with more deviant IEA in B2. We propose to test B1 psychosis cases
with clozapine vs. risperidone (n=40/group clinical trial completers), over a 6 week cross-titration (to therapeutic
plasma levels) and a 9 week stable dose extension, predicting that the B1/clozapine group will respond
significantly better, as measured with total PANSS, than the B1/risperidone group and also better than either B2
group. It is our hypothesis that the cortical attractor networks will be normalized and their function increased by
the increase in intrinsic EEG activity.

Public health relevance
Project Narrative Treatment advances in psychosis are limited by the use of phenomenology-defined diagnoses based on symptomatic outcomes, rather than by neurobiological constructs monitored by quantitative characteristics. The Bipolar-Schizophrenia Network for Intermediate Phenotypes (B-SNIP) uses biomarkers to define psychosis subgroups with the goal of testing the advantages of B-SNIP biomarkers for diagnostic and therapeutic decisions, consistent with principles in the NIMH Strategic Plan. We propose to test Biotype1 psychosis subgroup with clozapine, and predict a differential clinical response to clozapine compared with Biotype2, marked by normalization of IEA, cortical attractor network activity and an advantage over usual antipsychotic drugs, establishing low IEA in Biotype1 as a predictive biomarker for clozapine efficacy.